Genomic and Bioinformatics Core

The Genomics and Bioinformatics Core will provide resources and technical and bioinformatics support for the application of massively parallel sequencing-based technologies to the understanding of regulated gene expression in macrophages, T cells, B cells and endothelial cells. The Genomics and Bioinformatics Core will thereby enable the acquisition and sophisticated analysis of data generated by ChlP-Seq, RNA-Seq, GRO-Seq and Ribo-Seq experiments. These methods provide extremely powerful approaches to addressing key mechanistic and pathophysiologic questions by each ofthe four projects ofthe PPG.

Public health relevance
RELEVANCE (See instructions): The ability to globally evaluate gene expression and transcription factor location using massively parallel DNA sequencing approaches provides a relatively unbiased approach to determining functional roles of these factors and upstream signaling pathways in regulation of cellular phenotypes. This information is likely to provide new insights into how specific programs of gene expression in macrophages, T cells, B cells and endothelial cells are altered in atherosclerosis.